HORMONAL INFLUENCES OF PHARYNGEAL MUSCLE FUNCTION AWAKE AND ASPLEEP

The purpose of this study is to determine how female hormones influence muscles in the upper airway. This study is aimed at better understanding sleep apnea.